Supplement to Clinical, Genetic, and Cellular Consequences of Mutations in Na,K-ATPase ATP1A3

The ongoing NIH/NINDS-funded study of ‘Clinical, Genetic, and Cellular Consequences of
Mutations in Na, K-ATP1A3’, which is in its 14th year, has generated significant knowledge and
corresponding hypothesis for clinical advances. While a major strength of this study is the
extensive follow-up data from 2008 on, the associated complexities of collecting data over
multiple funding cycles also leads to challenges and logistic hurdles including use of a now
outdated custom-built electronic data capture system and inconsistent clinical research forms
and associated data dictionaries over multiple cycles of the parent grant.
The broad objective of the proposed Administrative Supplement is to address those
challenges by restructuring the data to produce optimally efficient analytical data sets which can
subsequently advance scientific discovery. This broad objective will be accomplished through
the following Specific Aims:
1) Comprehensively examine and restructure the current electronic data capture system
and associated databases to optimize utility of the ongoing data
2) Create analytical datasets that will facilitate subsequent publications on 1) discovery of
ATP1A3-related disease and their changes over time and 2) causative and risk factor
evaluation of ATP1A3 mutations.
Aim 1 will comprehensively examine the current data structure, recode variables to eliminate
inconsistencies across the cycles of data, design and develop a new tabular database model in
an Oracle SQL database, and migrate the previous data into this new tabular model. Aim 2 will
create analytical datasets from the tabular model in R statistical software, with corresponding
data dictionaries. These data will include long and wide format files and R markdown files using
reproducible and transparent code for production of all publishable manuscript projects.
To conduct the proposed data management and associated application development, the
Supplement will provide funding for services from Research Information Systems (RIS) and the
RIS has experienced programmers/analysts who assist UB investigators with all aspects of
web-based systems development, application development and support, and providing other
integrated information services. In summary, these aims will directly contribute to the first two
Specific Aims of the parent grant through production of high-quality data over nearly two
decades of data collection and will facilitate rigorous implementation of novel methods to
optimize the scientific values of these significant data.

Public health relevance
Understanding how genetic mutations impact human health requires complex long-term studies of human subjects. Doing so, however, leads to many complexities in the resulting data sets which make it challenging to produce trustworthy research findings. This study will restructure existing data and create ways to have reproducible findings from a highly significant clinical study on genetic mutations that can lead to disabling diseases.